Administrative Core

ABSTRACT – Administrative Core
The Administrative Core will support the coordination of efforts across the Center's research projects and cores
and activities to advance integration into the broader HIPC network. The overarching goal of the Administrative
Core is to ensure that the Projects and Cores successfully achieve the goals laid out for each unit and for the
program as a whole. The specific responsibilities of the Administrative Core are: (1) provide the infrastructure
and operational oversight for the overall management and coordination of the projects and cores; (2) promote
effective collaboration and communication within the HIPC-Stanford Center and with the broader HIPC
network; (3) provide and effective, centralized unit to manage finances and resources; and (4) broadly
disseminate results and report Center activity. Dr. Pulendran, the overall PI of the HIPC-Stanford Center, is the
Core Lead of the Administrative Core and he will be assisted by a Program Manager and an Administrative
Assistant. The Administrative Core will provide fully integrative administrative services for the management,
communications, coordination, and financial administration of the Center. The Core will ensure productive
collaborations through efficient management, leveraging the expert administrative and financial management
resources of Stanford University to make the HIPC-Stanford Center outstanding in generating high impact
research.